Etiology of Impaired Counterregulation in Glucose Homeostasis: Exploring the Roles of Glucagon, Somatostatin, Cortisol, and Epinephrine through Mathematical Modeling of Oral Glucose Tolerance Tests

PROPOSAL SUMMARY
Glucose homeostasis is tightly controlled in animals with plasma glucose levels maintained in a narrow range.
While insulin, secreted by the beta cell, regulates by promoting efficient glucose disposal and suppressing
glucose release from the liver when glucose levels rise, glucagon, secreted by the alpha cells, counterregulates
by facilitating glucose release from the liver through glycogenolysis and gluconeogenesis when levels fall.
Epinephrine, cortisol and growth hormone play supporting roles in glucose counterregulation. Impaired
counterregulatory responses can lead to hypoglycemia, a potentially fatal condition. Hypoglycemia is frequently
experienced by type 1 and late-stage type 2 diabetics, which limits the use of aggressive therapies in disease
management. The etiology of this impaired counterregulation is not well understood. On the other hand, alpha
cell dysfunction (impaired inhibition of glucagon secretion by glucose) leads to elevated fasting glucose levels
and diminished early suppression of glucagon after glucose challenge. This form of impairment exacerbates type
2 diabetes and may contribute to its development and progression. I propose to study both forms of impairment.
In oral glucose tolerance tests, diminished early suppression of glucagon followed by greater late glucagon
suppression is observed in type 2 diabetics. This leads to worsened hyperglycemia followed by hypoglycemia.
If the mechanism behind persistent glucagon suppression and delayed recovery is fully elucidated, it would be
possible to protect against hypoglycemic events. I propose to explore the different mechanisms of somatostatin
and GLP-1 mediated regulation of glucagon secretion by extending the parsimonious model of glucose-insulin-
glucagon dynamics I developed. Reactive Hypoglycemia (RHG) occurs a few hours after ingesting a
carbohydrate rich meal. Plasma glucose levels drop below 55 mg/dl and the patient displays neuroglycopenic
symptoms which are relieved by glucose ingestion. There is currently no definitive explanation for this behavior.
I will extend the glucose-insulin-glucagon minimal model I developed to include the other hormones and validate
the model with data from OGTT studies of patients with RHG. I will also investigate the role of insulin in
potentiating RHG. An overarching question in type 2 diabetes pathophysiology is the nature of disease
progression from normal through prediabetic to overt diabetic state. The critical role of alpha cell dysfunction in
disease development and progression has not yet been studied. I will interface the glucose-insulin-glucagon
model I developed with existing disease progression models. This will identify the role of alpha cell dysfunction
and glucagon action in development and acceleration of type 2 diabetes. I will study the etiology of hypoglycemia
in aims 1 and 2 and the impact of alpha cell dysfunction in type 2 diabetes through longitudinal modeling of
disease progression in aim 3.

Public health relevance
PROJECT NARRATIVE Glucose homeostasis is maintained primarily by the action of the regulator, insulin and the counterregulators, glucagon, cortisol, epinephrine, and growth hormone, and impaired counterregulation can lead to both hyper- and hypo-glycemia, causing chronic and acute pathologies. Alpha cell dysfunction and impaired glucagon secretion exacerbate type 2 diabetes which has reached epidemic proportions worldwide and places enormous burden on the healthcare system. The mechanisms and contribution of impaired counterregulation to type 2 diabetes and development of hypoglycemia will be studied.